RAPID ACCELERATION OF DIAGNOSTICS (RADX) PROGRAM TECH

We will provide a SARS-CoV-2 testing solution that can be performed by a user in the comfort of their home. The test provides >95% sensitivity and >98% specificity compared to gold-standard qPCR assays, with a result provided in 30 min. It consists of a disposable â??instrumentedâ? cartridge and a mobile App. The test can be easily performed by a lay user. The App provides step by step directions and allows results to be analyzed and recorded for transmission to a healthcare professional. This system offers several benefits compared to current lab tests including, expansion in testing without burdening the healthcare system, enabling businesses to reopen by allowing the frequent monitoring of the workforce, and use by counties and healthcare systems for epidemiological monitoring at mobile and portable test sites. From a Users perspective, this test allows them to perform all steps of performing a test from ordering online to receiving a test result without visits to a testing location reducing the risk of exposure to SARS-CoV-2. Testing at home is particularly critical for at-risk populations such as individuals in old age homes, diabetic patients, testing in remote areas such as farms. This test can also be expanded to diagnose flu in the future. Additionally, this device can also be used in larger social gatherings such as cruise ships and conferences. The solution can be combined with other telehealth services and can enable early diagnosis in high risk populations. The solution can also be combined with contract tracing apps and solutions.